Measuring Dynamic Capability of Adult Day Health Services in the US

This research project aims to develop a theory-driven, structured assessment tool with content and construct validity to evaluate the dynamic capabilities (DC) of Adult Day Service (ADS) providers. DC is defined as an organization’s ability to adaptively build, reconfigure, and integrate internal and external competencies to optimize effectiveness in changing environments. The project addresses three significant challenges in ADS research: the neglect of population patterns and organizational factors in current measurement practices, the lack of responsiveness research despite changing needs and policies, and limited research on how ADS providers serve different segments of the older adult population. Building upon previous pilot work, the primary objective is to develop a structured assessment tool to evaluate the DC of ADS providers, with attention to variation across service contexts. The development of the tool entails conducting in-depth interviews with ADS administrators, expert consultation with the National Adult Day Services Association (NADSA) panel and pretesting with a select group of ADS administrators. The finalized assessment tool will then be deployed in an online survey targeting over 4,000 registered members and non-members nationwide. This research project aims to illuminate the adaptability, management practices, and organizational factors shaping the capability of ADS providers to serve a changing older population in a dynamic and challenging environment. The findings will offer evidence-based recommendations to enhance the capabilities of ADS providers, enabling them to effectively respond to anticipated changes in demographics, technology, and policies. This project will also bolster the research capacity at California State University, San Bernardino (CSUSB), a predominantly teaching institution, and foster the professional development of the Principal Investigator and student researchers. The active involvement of graduate and undergraduate students from various disciplines will provide invaluable supervised research experience and mentorship. The requested funding will support faculty-led research and create an enriched research environment at CSUSB, advancing the understanding of ADS providers' dynamic capabilities and their role in supporting the diverse needs of the aging population.

Public health relevance
This project will develop and validate an evidence-based tool to assess the adaptability and strategic responsiveness of Adult Day Service providers. Strengthening the dynamic capabilities of these organizations will enhance their ability to meet the evolving needs of aging adults and support healthy aging through sustainable, community-based care.